Family Psychoeducation for Adults with Psychotic Disorders in Tanzania (KUPAA trial)

PROJECT ABSTRACT
Family psychoeducation for adults living with psychotic disorders in Tanzania (KUPAA Trial)
Psychotic disorders such as schizophrenia contribute to the global burden of disease in low- and middle-
income countries (LMICs) yet mental health services have been severely neglected. Family Psychoeducation
is an evidence-based practice from high-income countries that could have a significant impact in settings such
as Africa and other regions worldwide where resources are limited and family involvement in treatment is
fundamental. In response to PAR-21-130, this R01 will evaluate the impact of a culturally tailored version of
family psychoeducation called KUPAA (meaning “to soar” in Swahili) that is group-based and family-involved in
a low-income country context. The KUPAA intervention was recently pilot tested with adults living
schizophrenia-spectrum disorders and their families in Tanzania. The proposed hybrid effectiveness-
implementation clinical trial would individually randomize patient-caregiver pairs to either the group-based
intervention or the standard of care across 14 health facilities in four regions of Tanzania. The overall objective
is to improve recovery outcomes for individuals with schizophrenia-spectrum disorders. Aim #1: Determine the
effectiveness of KUPAA vs. standard of care for an outpatient population (n=432) by reducing disability and
improving quality of life (primary outcomes); and reducing hospitalizations and reducing perceived family
burden for caregivers (secondary outcomes) among matched patient-caregiver dyads. Aim #2: Examine the
mechanisms of change underlying KUPAA as a group-based, family-involved intervention. Aim #3: Evaluate
implementation outcomes guided by the Consolidated Framework for Implementation Research (CFIR) via
mixed methods (n=122 semi-structured interviews, observational data, cost data). This project is a
collaboration between the University of North Carolina at Chapel Hill, Duke University and four Tanzanian
institutions: Muhimbili University of Health and Allied Sciences in Dar es Salaam, Mbeya Zonal Referral
Hospital in Mbeya, Mirembe National Mental Health Hospital in Dodoma, and Kilimanjaro Christian Medical
University College in Moshi. This proposal aligns with the NIMH cross-cutting global mental health theme and
will contribute to NIMH’s goal of advancing mental health services to strengthen public health by providing
insights on an adapted evidence-based practice designed for lower-resource settings that could also inform
domestic implementation strategies for scaling family psychoeducation in the U.S.

Public health relevance
PROJECT NARRATIVE Family psychoeducation for adults living with psychotic disorders in Tanzania (KUPAA Trial) The proposed research is relevant to public health because the mental health needs of individuals with psychotic disorders in low-resource countries have been severely neglected, due in part to a lack of culturally tailored and evidence-based interventions. Family psychoeducation (FPE) is an evidence-based practice from high-income countries that could have a significant impact in settings such as Africa and other regions worldwide where resources are limited, families are largely responsible for care and support, and traditional beliefs and treatments are common. This R01 will test the effectiveness and mechanisms of action of a newly adapted and culturally tailored version of FPE called KUPAA for adults living with psychotic disorders in Tanzania which aligns with NIMH Strategy 4.2.B, “Building models to scale-up evidence-based practices for use in public and private primary care, specialty care, and non-traditional settings.”